The contribution of macrophage subpopulations to axon degeneration, nerve inflammation, and regeneration of the injured sciatic nerve

ABSTRACT
The most common forms of nervous system injury are traumatic lesions to peripheral nerves. Although axonal
regeneration in the periphery is more robust than in the central nervous system, neuronal regeneration is often
incomplete and associated with partial or complete loss of motor and sensory function, and the development of
neuropathic pain. After injury, the distal portion of severed nerve fibers shed their myelin sheath and rapidly
disintegrate, a process called Wallerian degeneration (WD). Blood-borne immune cells rapidly enter the injured
nerve to aid repair Schwann cells (rSC) and nerve resident macrophages (Mφ) in the removal of degenerated
myelin and axon remnants. Additionally, Mφ contribute to nerve debridement by phagocytosis of apoptotic cells
(AC) that accumulate in the injured nerve, a process termed efferocytosis. Clearance of AC before they undergo
lysis is critical to prevent secondary necrosis. Moreover, efferocytosis triggers Mφ reprogramming from a pro- to
anti-inflammatory phenotype. This process has only recently been identified as a function of Mφ after sciatic
nerve injury. The receptor mechanism of Mφ efferocytosis and its importance to nerve repair remain unknown.
Single cell RNA-sequencing (scRNA-seq) of injured mouse sciatic nerve identified Mφ subpopulations
expressing low-density lipoprotein receptor related protein 1 (Lrp1), a well characterized phagocytic receptor that
has been linked to Mφ efferocytosis and reprogramming in non-neural models of inflammation and injury. The
goal of this proposal is to understand whether efferocytosis is a unique function of specific Mφ subpopulations
and how it contributes to overall nerve health after injury. The central hypothesis to be tested is that
efferocytosis is a macrophage subpopulation specific function mediated by LRP1 to facilitate
macrophage reprogramming, inflammation resolution, and axon regeneration. To test this hypothesis, two
Specific Aims are proposed. Aim 1 will use a combination of FACS and scRNA-seq of phagocytic cells isolated
from injured nerves of mouse lines expressing fluorescent reporters labeling either neutrophils or myelin to
determine whether Mφ subpopulations exist that are specialized for efferocytosis or myelin phagocytosis,
respectively. Aim 2 will assess the contribution of Lrp1 to Mφ function and nerve recovery using a genetic mouse
model in which Lrp1 is conditionally ablated in monocytes and Mφ (Lrp1 cKO). Efferocytosis will be assessed by
adoptively transferring neutrophils isolated from CD45.1;tdTomato “universal donor” mice into Lrp1 cKO mice on
a CD45.2+ background. Inflammation and neural repair in the absence of Lrp1 in Mφ will be assessed using a
combination of molecular, biochemical and behavioral assays. The proposed studies are expected to reveal a
targetable mechanism in a specific Mφ population that impacts inflammation resolution, functional recovery, and
pain development after acute nerve trauma. Understanding the cellular and molecular mechanisms by which
immune cells contribute to neural repair may provide new avenues for treating peripheral nervous system injury
and disease.

Public health relevance
PROJECT NARRATIVE Communication between the cells of the peripheral nervous system and the immune system can determine the extent to which nerves recover after injury. The proposed project will identify key molecular mechanisms involved in the macrophage response to peripheral nerve injury and how these mechanisms contribute to nerve fiber repair. The results of this project will expand the knowledge base of the emerging field of neuroimmunology and provide potential therapeutic targets for the treatment of peripheral nerve injury and disease.